Optimal tuberculosis screening and tuberculosis preventive therapy delivery strategies to improve maternal and birth outcomes among pregnant women with HIV in Uganda: a randomized trial

PROJECT SUMMARY
Pregnancy and the early postpartum period are times when women, especially women with HIV, are at highest
risk for tuberculosis (TB). To reduce TB burden among all people with HIV, WHO recommends 1) intensified
case finding (“ICF,” systematic TB screening followed by confirmatory TB testing for all who screen-positive) at
every clinic visit and 2) immediate TB preventive therapy (TPT) for eligible individuals who screen-negative, in-
cluding pregnant women with HIV (PWWH). Both ICF and TPT are particularly important during pregnancy to
reduce risk of poor maternal and fetal outcomes. However, there are two main problems with the current
approach to ICF and TPT for PWWH. First, symptom screening – the most widely used screening tool for TB –
has unacceptably poor sensitivity among PWWH, missing up to 70% of all PWWH with TB, and performs
worse with repeated rounds of screening. Second, the optimal timing of TPT is unclear because studies of
PWWH receiving TPT have reported conflicting results, leading to inconsistent international guidelines on the
use of TPT in pregnant women. New options for TB screening (CRP, C-reactive protein) and TPT
(rifapentine-based short-course regimens) are now recommended by WHO and data among a general
population of people with HIV suggest better accuracy and tolerability, respectively, relative to traditional tools.
Definitive evidence is now urgently needed to determine whether CRP and/or short-course TPT can improve
pregnancy outcomes at antenatal clinics in Africa, where TB remains a leading cause of non-obstetric maternal
death. As such, we propose a highly efficient and innovative study using a sequential, multiple assignment,
randomized trial (SMART) design to conduct a two-stage randomized trial to determine the optimal TB
screening strategy and optimal timing of TPT initiation for PWWH. For the TB screening trial (Aim 1), we will
randomize 1,500 PWWH presenting for routine antenatal care in Uganda to either CRP or symptom-based TB
screening for the duration of their pregnancy and up to 6 months postpartum. The primary outcome for Aim 1
will be the proportion of all TB cases detected. For the TPT delivery trial (Aim 2), we will further randomize
screen-negative PWWH enrolled in Aim 1 to either immediate (antenatal) TPT or deferred TPT. We will
compare composite safety outcomes (primary outcome of spontaneous abortion, stillbirth, preterm birth, low
birthweight, neonatal death) and composite effectiveness outcomes (co-primary outcome of maternal 2-year
TB incidence and all-cause mortality) of immediate and deferred TPT. For Aim 3, we will use data collected
from Aim 2 and IGRA results to construct a third TPT arm (targeted TPT) where immediate TPT is targeted to
IGRA+ (high TB risk) PWWH and deferred for IGRA- (low TB risk) PWWH. We will compare safety and
effectiveness outcomes of targeted TPT to the two untargeted (immediate and deferred) TPT strategies. This
work will generate important data that will be critical to the future development of pregnancy-specific TB control
activities, thus changing standard practice to improve the health of 1.3 million PWWH who give birth each year.

Public health relevance
PROJECT NARRATIVE Because pregnant women have been excluded from clinical research, including tuberculosis (TB) research, little is known about diagnosing, treating and preventing TB in pregnant women. We plan to perform a two- stage randomized trial that will identify best practices for screening pregnant and postpartum women for active TB (screening by symptoms vs. C-reactive protein levels) and the optimal timing of TPT initiation, relative to pregnancy (immediately during pregnancy or deferred to postpartum) and whether immediate TB preventive therapy should be limited to just those women with highest TB risk. Because undiagnosed TB among pregnant women with HIV is associated with many devastating complications to both the mother and fetus, this research has the potential to improve maternal and birth outcomes worldwide.